BLRD Research Career Scientist Award Application

The etiology of Parkinson's disease (PD) is largely unknown. Preclinical and epidemiological studies provide a
strong link between old age, prior exposure to pesticides and the increased risk of developing Parkinson's
disease. This is of particular relevance to the VA because military personnel are often exposed to environmental
toxins, including pesticides, during deployment. Moreover, the veteran population is older than the U.S.
population and thus at increased risk. Recent evidence supports a role for elevated biogenic aldehydes in PD.
The work proposed will not only help to elucidate the mechanisms underlying Parkinson's disease, but it will
determine whether agents that lower biogenic aldehydes may be neuroprotective in Parkinson's disease. The
test agent and potential alternatives are FDA-approved drugs for which there is abundant information on their
safety and efficacy. Therefore, if these preclinical studies show efficacy in models of PD, then they may be more
easily tested clinically.

Public health relevance
Parkinson's disease (PD) is the second most prevalent age-related neurodegenerative disorder, after Alzheimer's disease, affecting up to 5% of the population aged 65 – 85 years. Veterans are at increased risk for PD because the veteran population is older than the United States population as a whole and because veterans are more likely to have been exposed to toxic environmental agents during deployment. Current therapies only treat the symptoms of the disease and do prevent or delay its progression. A growing body of evidence from our lab and others has implicated impaired removal of toxic biogenic aldehydes in affected brain areas. Our studies will help to identify drugs that can remove or prevent the accumulation of biogenic aldehydes and alleviate the burden of Parkinson disease in veterans.